Evaluating the therapeutic potential of vagal CART circuitry for treating metabolic disease

Abstract
Obesity is a global crisis with severe health and economic repercussions. One of the root causes of obesity is
overeating diets rich in fats and sugars. The vagus nerve is a critical conduit for gut-brain communication that
senses nutrients and in turn controls feeding behavior. During the previous grant, we established novel
technical advances to manipulate vagal sensory neurons in freely behaving animals and leveraged them to
identify gut-brain circuits that separately control satiety and reward. The current proposal builds on that
previous work to address how these circuits are changed in diet-induced obesity. We hypothesize that impaired
vagal signaling develops early in response to high-fat/high-sugar diet, but that downstream central nervous
system (CNS) circuits, for satiety and reward, remain functional and could therefore be targeted to treat
obesity. We will test this with three specific aims: (1) determine the timing and extent of impaired vagal
sensing, using in vivo calcium imaging of vagal sensory neurons, and identify mechanisms for disruption using
state-of-the-art transcriptomic profiling; (2) assess whether CNS satiety and reward circuits that are
downstream of vagal signaling remain functional in obesity; and (3) address the poorly understood role
nigrostriatal dopamine in the CNS control of food intake and obesity, particularly its impact on food preference
and motivation. The proposed research will advance our understanding of gut-brain signaling in obesity and, if
successful, promises to unveil new targets for obesity treatment.

Public health relevance
Project Narrative Obesity is a serious health concern, estimated to contribute to one-third of the deaths in the U.S. This project examines how meal-related signals between the gut and different brain regions, which in turn control what and how much we eat, are impaired in obesity to promote overconsumption foods rich fats and sugars and to lower motivation for low-calorie foods. Increasing our understanding of how and which feeding circuits are impaired in obesity will lead to more targeted strategies to help prevent and alleviate the detrimental effects of obesity.